Privacy-Preserving Connectivity for Rare-Disease Patients

Abstract / Summary
Safeguarding privacy of data assets – while simultaneously facilitating data sharing and
exchange – is paramount to sustaining the value creation of genomics for precision
medicine and population health. One of the most significant challenges for rare disease
studies in general is the lack of integrated, privacy-preserving platforms to facilitate efficient
patient recruitment and data sharing. Rare disease datasets are fragmented, incomplete,
and sparse. These barriers to data accessibility prevent efficient data aggregation,
translation to clinical benefits, and disease promotion to the global patient and scientific
communities. Without data sharing mechanisms that align incentives while preserving
security and privacy, fragmented and siloed data will severely limit the value of genomic
medicine in the future.
We aim to address these issues by designing and developing components enabling a
computationally feasible privacy-preserving rare disease community engagement platform,
emphasizing FAIR (findable, accessible, interoperable, reusable) data principles.
Specifically, we will deploy innovative cryptography technologies in the context of a web
application streamlining interaction, data exchange, and analysis between patients,
advocacy groups, researchers, and therapeutic developers. Building on our current secure,
HIPAA-compliant infrastructure, in Phase I of this fast-track proposal we will onboard our
existing Xia-Gibbs Syndrome (XGS) Registry to establish proof-of-concept while ensuring
the platform is readily generalizable to other rare diseases. In Phase II, as we onboard two
additional rare disease communities, we will implement software optimizations and
GPU-acceleration to ensure the platform can scale to a data privacy- and
ownership-preserving engagement platform and registry applicable to all rare disease
communities and datasets.
Ultimately, the approaches developed here will allow researchers and therapeutic
developers expanded ability to search for and retrieve essential patient data for rare disease
research. We anticipate the creation of such a tool will accelerate the growth of rare disease
registries worldwide, creating positive externalities benefitting the entire industry by
enabling widespread access to previously inaccessible data.

Public health relevance
Narrative Widespread access to analysis-ready patient data and engagement with patient communities are arguably the most significant bottlenecks for advancing research and therapeutic development for genetic disorders. We address these bottlenecks by facilitating the development of a privacy-preserving rare disease community engagement platform and universal registry, emphasizing FAIR principles (findability, accessibility, interoperability, reuse). This tool will accelerate widespread, compliant, and secure sharing of existing data, and catalyze investment in generation of new rare disease datasets.